Epigenetic Regulation of Microglia Dopamine System Interactions

ABSTRACT
Adolescence is a time of increased risk and reward seeking behaviors, and 74% of adults with a substance use
disorder initiated use by 17 years of age, with many drugs of abuse acting through the dopamine (DA) system.
This makes understanding DA system development in adolescence of great importance to uncover the etiology
substance use disorders. In the rat, adolescence is a critical window of circuit refinement in the nucleus
accumbens (NAc), a dopamine (DA) rich brain region associated with reward. Microglia, the resident immune
cell of the brain, not only provides neuroimmune support but prunes synapses and receptors. We recently
demonstrated in rats that dopamine d1 receptor (D1r) peaks in adolescence and declines into adulthood, and
this decline occurs via a microglial-dependent phagocytic mechanism in males but not females. Importantly, this
downregulation of D1r in the NAc mediates termination of adolescent social play behavior in males. It is not
known what regulates microglial pruning behavior in the NAc. It is known that microglia phagocytosis across
brain regions due to chromatin remodeling altering transcriptional accessibility of required genes. Moreover,
microglial phagocytosis of synapses has been demonstrated to be dependent on neuronal activity. My central
hypothesis is that NAc microglial chromatin reorganization throughout adolescent development regulates
genomic accessibility and expression of phagocytic genes, mediating D1r phagocytosis directing social behavior
in males. I predict this occurs in a DA activity-dependent manner. To test these hypotheses, in Aim 1 I will
characterize genomic accessibility and gene expression with microglia, correlating phagocytic gene accessibility
expression through across adolescent development. This will provide a novel baseline characterization of
microglia through development and between sexes, potentially identifying sensitive periods of dynamic gene
regulation. In Aim 2 I will determine if dopaminergic signaling to the NAc is required for typical microglial
phagocytic activity and chromatin organization, impacting social behavior. This will demonstrate whether
microglial pruning of dopamine receptors during adolescence is dependent on neuronal activity and has
consequences for behavior. Collectively these data allows for powerful future directions investigating effects of
drugs of abuse on microglial development and function

Public health relevance
PROJECT NARRATIVE The development of the dopamine system is a tightly regulated process that has great implications on social and reward associated behaviors. Microglia, the resident immune cells of the brain, selectively engulf (phagocytose) dopamine receptors during adolescent development, however, what regulates this microglia function remains unknown. I will investigate the role of dopaminergic signaling in regulating microglial chromatin remodeling and phagocytic function through adolescence impacting social behavior—providing necessary foundational knowledge on microglial development in a key reward associated brain region.